Structural and Functional Analysis of Nucleocytoplasmic Protein O-Glycosyltransferases in Plants

Project Summary/Abstract
O-linked protein glycosylation orchestrates diverse signaling events in plant development in response to the
changing environment. We have discovered the first nucleocytoplasmic O-fucosyltransferase, SPINDLY (SPY)
in Arabidopsis, which together with its paralog SECRET AGENT (SEC), an O-GlcNAc transferase (OGT), post-
translationally modify the conserved DELLA family of transcription regulators, such as RGA, to control their ability
to modulate multiple signaling pathways. SPY-catalyzed O-fucosylation of RGA enhances the RGA interaction
with key transcription factors to suppress plant growth, whereas SEC-mediated O-GlcNAcylation weakens RGA
activity and promotes plant development. Despite their functional significance, how these two homologous
glycosyltransferases, SPY and SEC, have evolved distinct substrate specificities and how these two types of
glycosylation, O-fucosylation by SPY and O-GlcNAcylation by SEC, regulate the RGA conformation to influence
plant development at the molecular level have remained unknown. We propose to elucidate the molecular details
of SPY, SEC, and their substrate and product complexes, as well as the distinct structural and functional
consequences of RGA O-fucosylation and O-GlcNAcylation. Recent proteomic analysis has unveiled hundreds
of SPY and SEC substrates beyond RGA, highlighting the broad implication of protein glycosylation in regulating
cellular functions. In order to overcome the potential pleotropic effects brought by spy and sec mutations in planta
and decipher the functional consequences of O-fucosylation and O-GlcNAcylation for specific target proteins,
we will develop nanobody-fused SPY and SEC variants for precise target modification. Collectively, our study
will fill the critical knowledge gap about the structural and functional consequences of protein glycosylation in
plants. As SPY-like genes are conserved in diverse organisms, including plants, bacteria, and parasitic protists,
and as SEC-like (OGT) genes are broadly distributed in plants and animals, a molecular understanding of these
enzymes and their distinct structural and functional consequences will have a profound impact in plant biology,
agriculture, and human health and diseases.

Public health relevance
Project Narrative (Public Health Relevance Statement) Protein glycosylation plays an important role in all kingdoms of life by regulating cellular responses to metabolic and environmental changes. Defects in protein glycosylation have been linked with abnormal plant development, parasitic virulence and viability, and a variety of human diseases, such as cancer, diabetes, and neurodegenerative diseases. Therefore, our proposed structural and functional studies of two distinct glycosyltransferases, SPY and SEC, and their opposing effects on key transcription regulators will reveal novel molecular insights into the genetic regulation by two distinct types of intracellular protein glycosylation: O- fucosylation and O-GlcNAcylation, with profound implications in agriculture and public health.